Core D - Data Management and Statistics Core

CORE D- ABSTRACT/SUMMARY
The Data Management and Biostatistics (DMB) Core is an integral component of our team project,
“Strategies for Targeting Astrocyte Reactivity in Alzheimer’s Disease (AD) and AD related dementia (STAR-
ADRD)”. The goal of the DMB Core is to provide a comprehensive, multi-disciplinary resource for four STAR-
ADRD projects by constructing and maintaining a centralized data repository and drawing biostatistical expertise
for the completion of their research. A unique aspect of this Core is the design and utilization of a Structured
Query Language (SQL) server to store analytical data and metadata related to the four projects in a single
location for cross-project integration. The DMB Core will closely and regularly interact with other investigators to
ensure that all data are collected and deposited in alignment with the goal of generating rigorous and
reproducible data repository. Given that interdisciplinary research requires researchers to use methods and data
from a range of disciplines, the role of the DMB Core is vital to the success of the STAR-ADRD team. The DMB
Core will support these responsibilities through the following specific aims.
Aim 1: Maintain and expand an integrated data warehouse and suite of Browser-based data collection
applications and reporting platforms for the STAR-ADRD Cores and projects. Data management efforts will focus
on collecting, storing, and sharing high quality data according to the standard operating procedures.
Aim 2: Provide expertise on tailored and integrated statistical analyses. The DMB Core will provide statistical
analyses individually tailored to the STAR-ADRD projects and Cores’ needs. The DMB Core will actively interact
with STAR-ADRD investigators, examine their research hypotheses, plan and suggest appropriate statistical
analysis methods and models, build tailored analysis pipelines, interpret and discuss results, create graphs and
tables for presentations and manuscripts, and write the statistical analysis section in manuscripts. Further, the
DMB Core will develop and apply statistical methodology on data harmonized and integrated across the four
STAR-ADRD projects.
Aim 3: Host training in data management practices for the research team. The DMB Core will offer in-person (or
Zoom) data quality and management workshops with the entire STAR-ADRD team. The materials developed
and used for workshops will be documented and shared with STAR-ADRD team members.
All four projects proposed in this P01 require data management and biostatistical expertise to ensure that
all data are reliable and statistically analytical. The DMB Core will play a key role in facilitating synergies across
the STAR-ADRD projects and Cores.